Supplement to Support the Acquisition of a High-Precision 3D Printer

Administrative Supplement Request for Equipment Purchase
Project Number: R01NS134604
Project Title: Ionically Conductive Polymeric Biomaterials and Grafts for Nerve Regeneration
Requested Equipment: High-Precision 3D Printer
This request is for an administrative supplement to purchase a high-precision 3D printer essential
for advancing the aims of project 1R01NS134604. The parent grant hypothesizes that our
ionically conductive (IC) chitosan scaffold platform, combined with electrical and chemical
stimulation, can repair large-gap peripheral nerve injuries (PNI).
Recent and unanticipated findings from our ongoing studies have demonstrated the unexpected
efficacy of our IC scaffolds in long-gap nerve repair. In a key discovery, our IC scaffolds
successfully repaired critical-size nerve defects of up to 4 cm. Remarkably, when arranged in a
looped configuration, the 4 cm scaffolds produced even larger compound muscle action potential
(CMAP) amplitudes than the 2 cm scaffolds, indicating successful long-gap innervation. These
promising results present an exciting opportunity to explore the design optimization of these
scaffolds and electrodes for large-gap nerve regeneration.
To capitalize on these compelling findings, the acquisition of a high-precision 3D printer has
become essential. This equipment is vital to overcoming the limitations of our current freeze-
drying fabrication methods. The printer will provide precise control over scaffold pore size and
architecture, enhance the delivery of electrical and pharmacological stimuli, and improve
scalability—capabilities that are now required to build upon our unexpected results. Without this
technology, our ability to advance the scaffold design and its translational potential will be
significantly constrained.
We are requesting $100,000 in supplemental funds for the 3D printer. Demonstrating a firm
commitment to this research direction, our institution’s Department Chair and Vice Chancellor
for Research have agreed to provide gap funding to support this acquisition.

Public health relevance
Project Narrative This project addresses the significant clinical challenge of large-gap peripheral nerve injuries by developing a novel, ionically conductive (IC) biomaterial scaffold. The foundational hypothesis is that these chitosan scaffolds can synergistically deliver electrical and chemical stimulation to promote functional nerve repair, with initial results already showing outcomes comparable to the current gold-standard autograft treatment. This research aims to optimize the scaffold design using high-precision 3D printing and validate its long-term safety and efficacy in restoring nerve function, creating a new platform with high translational potential.